Life’s end Benefits of CannaBidiol and TetrahYdrocannabinol (LiBBY) Open-Label Extension (OLE) Study

PROJECT SUMMARY/ABSTRACT
This project will be conducted in the context of the Alzheimer’s Clinical Trials Consortium (ACTC), which is a
consulting group of over 100 sites (with 30 leading clinical sites in the Steering Committee) dedicated to
Alzheimer’s disease (AD) research and the infrastructures supported by the National Institute on Aging (NIA).
The Life’s end Benefits of CannaBidiol and TetrahYdrocannabinol (LiBBY) Study is the first phase 2,
multicenter, randomized, double-blind, parallel-group, placebo-controlled,12-week study to evaluate the
efficacy and tolerability of an oral combination of two cannabinoids, tetrahydrocannabinol (THC) and
cannabidiol (CBD), in hospice care eligible patients with agitation and Alzheimer’s disease (AD) or other types
of dementia (HAD). We here propose to continue the LiBBY Study beyond the initial 12 weeks with an open
label extension (OLE) study design. Although the double-blind, placebo-controlled study will offer important
information about the efficacy of the THC/CBD combination in this population, other relevant clinical questions
still need to be answered. Specifically, 1. do participants treated with THC and CBD maintain their level of
response with prolonged exposure and do participants treated with placebo respond to the THC/CBD oral
combination during the OLE study?, 2. does treatment with THC and CBD have an impact on lifespan and site
of care with prolonged exposure?, 3. does treatment with THC and CBD impact quality of life with prolonged
exposure?, and 4. does treatment with THC and CBD have an impact on caregiver burden with prolonged
exposure? Furthermore, despite the fact that our approach may be controversial, the investigators feel strongly
that for humanitarian reasons, active treatment should be offered to all individuals in the study including those
receiving placebo in the double-blind, placebo-controlled study. To that end, since the double-blind, placebo-
controlled study is ongoing, the Alzheimer’s Therapeutic Research Institute (ATRI) has agreed to provide
bridge funding to allow individuals currently in the double-blind, placebo-controlled study to proceed to the OLE
study until LiBBY OLE is funded.
To address the questions stated above, we propose to conduct a 12-week, OLE study to be offered to
participants who complete the double-blind, placebo-controlled LiBBY Study.

Public health relevance
PROJECT NARRATIVE The Life’s end Benefits of CannaBidiol and TetrahYdrocannabinol (LiBBY) Open-Label Extension (OLE) Study is designed to provide the researchers with the opportunity to evaluate the effects of the tetrahydrocannabinol (THC)/cannabidiol (CBD) oral combination as a treatment for agitation in hospice care eligible patients with agitation and Alzheimer’s disease (AD) or other types of dementia (HAD) after prolonged exposure, and address scientifically and clinically important questions within this population. Additionally, the LiBBY OLE Study will offer subjects who complete the double-blind, placebo-controlled LiBBY Study with the opportunity to begin or continue receiving the THC/CBD oral combination.